VISION RESEARCH CORE GRANT

SUMMARY – ADMINISTRATIVE CORE
The Administrative Core ensures that the five Service Cores are run efficiently and shared equitably among the
Vision Research Core Grant (VRCG) participating investigators. The Administrative Core communicates and
coordinates VRCG services for maximum use, and it provides strategic plans to meet the evolving needs of
participating investigators. The Administrative Core includes an evaluation plan to assess Core impact and to
promote continuous quality improvement.